A Multidisciplinary and Translational Approach to Hepatobiliary Malignancy

DESCRIPTION (provided by applicant): In summary, HCC is the third most common cause of cancer mortality and has the fastest growing mortality rate of any cancer in the US. There are limited treatment options for this cancer and despite the advance of modern chemotherapy, the long-term outlook for patients with liver tumors remains extremely poor. Intensive research efforts have been directed toward the identification of the mechanism of initiation and progression of HCC in hopes of developing biomarkers for early diagnosis and novel treatment strategies. In order to develop rational immunological strategies for treating liver malignancies, it is important to characterize the underlying host-tumor interactions. Our preliminary data suggests that there is an ineffective immune response to HCC, which is characterized by impaired CD response, increased populations of circulating CD4+CD25+ FoxP3 regulatory T cells (Treg) and soluble CD25. We found an elevation of Tregs with enhanced suppressive function in the peripheral blood of patients with HCC which correlated with stage and tumor burden of HCC. In addition, there was an overall level of T cell suppression (based on CD4 T cell proliferation assays) and a close relationship with soluble CD25 and overall tumor burden. Soluble CD25 represents a potential simple, ELISA-based biomarker in the serum of T cell activation (sCD25 is cleaved from T and NK cells on activation) and because recent evidence has suggested a role in tumor related immunosuppression. In this application, we will address the hypothesis that Tregs and CD25 are increased in peripheral blood of HCC patients and promote HCC development/progression via suppression of cell mediated CD4 and CD8 T cell responses, and depletion of Tregs and/or sCD25 would enhance cellular immunity against HCC. In Specific Aim 1 we will directly evaluate the mechanisms of sCD25 induction by human HCC and modulation of immune response. In Specific Aim 1, we will also evaluate our hypothesis in patients who develop HCC and will correlate the sCD25 levels and Treg frequency / function with HCC development, progression, and response to therapy. Our proposed study will provide critical insights into the function of Tregs in liver cancer. More importantly, using a well-characterized HCC patient cohort and a well characterized animal model, we will be able to develop novel diagnostic and therapeutic strategies for HCC. In Specific Aim 2, we will characterize the expression of TRAIL and its death receptor DR4 and DR5 in human HCC tissues, determine the efficacy of TRAIL agonists on human HCC cells cultured from resected cancer tissues, and initiate clinical trials in patients with HCC using HGS-ETR. This study (initiated based on our own research data) will be the first in the world to comprehensively investigate the therapeutic potential of TRAIL agonists in human liver cancer. The outcome of our in-vitro and in-vivo studies will provide critical insights into the global effect of TRAIL agonists on human organ systems, which is essential data for broad clinical applications.

Public health relevance
PUBLIC HEALTH RELEVANCE: In conclusion, this K24 application proposes to support a unique mentoring and training program that identifies and mentors MD trainees in gastroenterology /oncology/ and hepatobiliary surgery at an early critical point in their career. I have framed a thematically related proposal that includes coursework and research opportunities for molecular and clinical research training in hepatocellular carcinoma. Narrative In conclusion, this K24 application proposes to support of a unique mentoring and training program that identifies and mentors MD trainees in gastroenterology /oncology/ and hepatobiliary surgery at an early critical point in their career. I have framed a thematically related proposal that includes coursework and research opportunities for molecular and clinical research training in hepatocellular carcinoma. __SpecificAimsTextDelimiter__ IV. RESEARCH PLAN Dr. Nelson currently has a broad range of translational and clinical interests that form the basis for attracting and mentoring students, fellows, and junior faculty. While this application focuses on my current interests related to hepatobiliary malignancy, it is anticipated that future mentoring activities will not just be limited to what is laid out below. I have tried to arrange a thematic approach to a mentoring program in a novel area of great need for junior investigators. Currently Supported NIH Research: Overview of research program The focus of my current NIH funding is to examine the roles of CD8+T cells, regulatory T cells (CD4+CD25+ T cells), and plasmacytoid dendritic cells in HCV infection. These three components of the immune response are interconnected and tightly regulated by both host factors and viral factors. The overall experimental approach is to examine the effects of these cells in HCV-infected patients, focusing on the impact to immunopathogenesis and response to therapy. Mentoring Opportunities: Our translational approach to HCV, along with multiple related clinical trials (including liver transplantation) provide a rich source of projects for mentees. I currently have 2 GI fellows, one medical student, one junior faculty, and two post-docs involved in various aspects of HCV-related applications. I will be expanding the HCV research focus with a R01 renewal in 2010 that will transition more toward translational and clinicqal projects related to innate immunity and viral heterogeneity. I am serving as the primary mentor for Dr. Gary Wang, who recently received funding for a K08 award and is on faculty in our ID Division. Dr. Wang is a highly accomplished young investigator with a combined MD/PhD from Temple University and ID fellowship training from the University of Pennsylvania. Dr. Wang has received superb training as a postdoctoral fellow and now wishes to extend his expertise in pyrosequencing and bioinformatics to examine HCV sequence diversity in relation to viral persistence and treatment outcomes. In addition, I have also begun mentoring a new post doctoral candidate (Dr. Rebecca Gray) who has been accepted under our Cancer Center's T32 training grant who will address questions concerning aspects of HCV evolution and hepatocellular carcinoma. Lastly, we have a major research focus on defining the host and viral factors responsible for post-liver transplant HCV disease recurrence and have two active projects ongoing. In fact, I am currently mentoring Dr. Roberto Firpi in a project related to HCV recurrence after transplantation and he has submitted a NIH, K08 application. New research to be conducted under this award A. SPECIFIC AIMS: Hepatocellular carcinoma (HCC) is one of the most common malignant cancers worldwide. Except for surgical resection for early stage of cancer, there is no effective therapy. Novel and effective therapies are urgently needed. Our recent study suggests that there is an ineffective immune response to HCC, which is characterized by increased suppressive populations of cells: CD4+CD25+Foxp3+ regulatory T cells (Treg) and myeloid-derived suppressive cells (MDSC). We found an elevation of Tregs with enhanced suppressive function in the peripheral blood of patients with HCC which correlated with tumor burden and overall survival. We also found that MDSC cells are significantly increased in HCC using a novel, immune competent mouse model. Moreover, we discovered that Sorafenib, a multi-kinase inhibitor that is approved for advanced stage of HCC, down-regulates both Tregs and MDSCs, suggesting a novel mechanism of therapeutic effect. Considering that Sorafenib is the only approved therapy for advanced HCC it is important to explore the drug's mechanism of action and how HCC and the host immune system respond to the drug. Clinical observations have recently reported that drug resistance/tolerance can develop. One essential question is how drug resistance occurs at the cellular level or immunological level. The ultimate goal of our study is to develop a better understanding of the immunologic environment with HCC development and how Sorafenib and future therapies will impact the host anti-tumor immunity, especially suppressive cell populations. We hypothesize that HCC tumor development induces an immunosuppressive phenotype and that Sorafenib exerts a therapeutic effect through suppression of both tumor growth and impairment of Tregs and MDSCs. This central hypothesis will be tested through the following Specific Aims: Specific Aim 1: To determine the role of T regulatory cells (Tregs) and myeloid-derived suppressor cells (MDSC) in the development / progression of HCC and explore the therapeutic role of Treg / MDSC modulation in a pre-clinical liver cancer model. We will test the hypothesis that tumor-derived immune suppressive mechanisms occurs with the development of HCC and explore the role of surrogate immune markers in this process. Samples of peripheral blood will be collected prospectively in patients with HCC and a large control group of cirrhotics undergoing cancer surveillance. At least 150 HCC patients and 150 cirrhotic patients will be enrolled to this study. Peripheral blood samples will be analyzed for the frequency, phenotype, and function of suppressor cell populations (Treg and MDSC). The findings will be correlated with stage and clinical outcome of the diseases. To develop novel approaches for HCC based on the clinical findings, we will explore the therapeutic role of down-regulation of Treg/MDSC in an immune competent BALB/c mouse HCC model. These experiments will provide new insight into the role of the immune suppressive populations in the development of HCC, and provide preclinical data on the potential of these suppressor cells as therapeutic targets. Specific Aim 2: To examine the immunomodulatory mechanisms of Sorafenib therapy in HCC treatment. In this Aim, we will test the hypothesis that Sorafenib inhibits HCC through modulation of Tregs and MDSCs. Our preliminary data has shown that Sorafenib impacts the frequency and function of Treg and MDSC populations, leading to anti-tumor effects. We will systematically examine the underlying mechanisms using the BALB/c HCC cancer model, both with in vitro and in vivo studies. Moreover, we will also evaluate the impact of Sorafenib on Tregs and MDSCs in patients who are undergoing therapy. We plan to recruit 100 HCC patients for this study. These experiments will provide an insight into the immunomodulatory mechanism of Sorafenib, which may provide the scientific basis for developing improved therapies. Specific Aim 3: To determine the mechanisms of Sorafenib resistance/nonresponse in HCC. It has been clinically shown that patients have a viariable response to Sorafenib and our preliminary data demonstrate that HCC cells appear to develop tolerance to Sorafenib treatment. In this Aim, we will test the hypothesis that Sorafenib develops resistance through modulation of HCC intracellular signaling pathway and inability to modulate suppressor cell populations. To test the hypothesis, we will generate Sorafenib-resistant cell lines, and test the various mutations along the K-RAS, B-RAF, and EGFR pathway by extensive pyrosequencing analysis. We will also examine the Treg and MDSC response in patients who have developed Sorafenib resistance. These experiments will provide important knowledge as to the mechanisms for resistance to HCC drug therapy and allow for identification and targeting of new strategies to improve response. Specific Aim 4: Determine the Role of Aberrant TRAIL Receptor Expression in Human HCC and the Potential for Therapeutic Targeting Our hypothesis is that TRAIL Agonists (Mapatumumad; HGS-ETR1) are capable of inducing HCC apoptosis through TRAIL-death receptor pathway. The rationale is that TNF -related apoptosis inducing ligand (TRAIL) and its cognate death receptor (DR4 and DR5) pathway play a critical role in cellular apoptosis. TRAIL binding to either DR4 and DR5 activates a cascade of intracellular signaling that results in apoptosis. Our preliminary studies with TRAIL agonists indicate that treatment causes liver cancer cell death only, without apparent toxicity to normal primary hepatocytes. Our data also reveal that different cancer cell lines (Huh7 and LH86) may have different sensitivity to the TRAIL agonists. It is imperative to understand the underlying molecular basis. Not only do TRAIL agonists show therapeutic effectiveness but also the combination of TRAIL agonists and chemotherapy have been both mono- and combination therapy shown to improve the clinical outcome in other GI tumors. It is thus important to evaluate the therapeutic potential for HCC since DR4 and DR5 are selectively up-regulated on these tumor cells. In this project, we will aim at understanding the molecular basis for TRAIL-mediated tumor cell apoptosis and developing a TRAIL-based therapy for patients with HCC.